Developmental immunotoxicity of PFAS

PROJECT SUMMARY
The goal of this project is to determine how developmental exposure to a mixture of per- and polyfluoroalkyl
substances (PFAS) disrupts humoral immune defenses against respiratory virus infection. There is evidence that
PFAS affect the immune system, but uncertainty about underlying cellular mechanisms. This project builds on
preliminary evidence that developmental exposure to a mixture of PFOA, PFOS, PFNA and PFHxS perturbs the
response to influenza A virus (IAV) infection, including significantly fewer T follicular helper (Tfh) cells. Tfh cells
are critical drivers of humoral immunity, controlling antibody production, isotype switching, affinity maturation,
and immunological memory. Additional pilot data show that fewer Tfh cells in PFAS-exposed offspring correlate
with reduced IAV-specific antibody levels. Our results are exciting because, although changes in antibody levels
are often associated with PFAS, how developmental PFAS exposure alters key cellular events that underpin
humoral immunity is not known. The proposed research will test the central hypothesis that developmental
exposure disrupts Tfh cells, which contributes to alterations in B cell responses and antibody production. During
IAV infection, we can track responses of Tfh cells, germinal center B cells, and plasma cells over time using
multidimensional flow cytometry, and the kinetics of primary and anamnestic responses to IAV are well
established. The first aim will define the contribution of alterations in T cells and B cells to the effects of
developmental PFAS exposure on Tfh cells and anti-viral humoral immunity, including memory responses. The
second aim will delineate key parameters of developmental immunotoxicity of PFAS, including the critical window
during development that is most sensitive to PFAS exposure, and the dose-dependent and sex-dependent
nature of immune function changes caused by developmental PFAS exposure. This will include using ultra-high-
performance liquid chromatography coupled with high-resolution mass spectrometry to measure PFAS in the
offspring, allowing internal dose and immune function to be directly related. The third aim will identify the mode
of action through which PFAS affect immune function using conditional knockout mice and pharmacological
agents. This aim will resolve whether developmental immunotoxicity is mediated via peroxisome proliferator
activated receptors (PPAR). This research project will significantly advance knowledge of how developmental
exposure to a representative real-world PFAS mixture modulates the immune system. Major impacts include
that it will pinpoint cellular targets that contribute to clinical consequences, provide a framework to understand
sex differences in PFAS developmental immunotoxicity, produce new information to guide research in human
population studies, and refine our ability to identify at risk populations.

Public health relevance
PROJECT NARRATIVE This project uses cutting-edge approaches to establish how developmental exposure to a PFAS mixture affects the immune system. In the context of fighting human respiratory virus infection, we will define how PFAS influence immune function at cellular levels, parse sex differences, and establish dose-response relationships.